National Alzheimer's Coordinating Center

Project summary/abstract
NACC (as U01 AG016976, at University of Washington) has been active since 1999. The existing NACC
infrastructure is described in the Facilities and Resources Section of this application. The broad goals of
the past funding cycles are consistent with those of the current U24 RFA — that is, to serve as: a.) the
central hub for organizing and enabling communication within and outside of the ADRC program,
including annual meetings and steering committees; b.) a national data resource, collecting data from
the Alzheimer's Disease Research Centers (ADRCs) as well as affiliated data and sample repositories; and
c.) a facilitator of current and future AD/ADRD research.
NACC has considerable experience and success in reaching these goals, and is positioned for continued
success in a rapidly advancing field. New data and methods are appearing in areas such as biomarkers,
neuropathology, and tests for early detection. Through the strategic adoption of technological advances,
we will build on these accomplishments at an accelerated pace. Building on our already significant
capabilities, we will: promote and broaden communication within and outside of the ADRC program;
expand informatics capabilities of NACC consistent with FAIR principles; conduct and support
methodologic and applied research, leveraging deep expertise in biostatistics and data science; and
support early-career research scientists by providing peer-reviewed competitive funding for several
“junior investigators” each year. We aim to continue to improve our approach in each arena by
combining time-tested approaches with the new tools and innovations we are developing to meet the
changing scientific, technological, and communication needs of the NIA ADRC program and the field.

Public health relevance
Narrative NACC (as U01 AG016976, at University of Washington — now seeking renewal as a U24) has been active since 1999, and has established a standardized, longitudinal clinical database of over 42,000 individuals (with neuropathology data on over 6,100), as well as cross-sectional, retrospective data on roughly 66,000 individuals seen at ADRCs between 1984 and 2005. NACC has made these data freely available to researchers worldwide, resulting in hundreds of publications. We will modernize and intensify our informatics approach, making data access and use more efficient; will grow communication and coordination capabilities with the ADRCs and collaborating NIA projects; will develop and apply big-data research tools for the field; and will provide competitive, peer-reviewed research support for several new investigators each year. Together with the field’s leaders, NACC will innovate, develop, and drive solutions to meet the changing needs of the field as well as the NIA ADRC program.